A feasibility trial of functional precision cancer medicine to inform treatment selection in metastatic breast cancer

Title: A feasibility trial of functional precision cancer medicine to inform treatment selection in
metastatic breast cancer.
In metastatic breast cancer, with the notable exception of the HER2 paradigm, the promise of the genomic
“precision medicine” in which mutant driver genes in a patient’s tumor are identified and the encoded proteins
are targeted with therapeutic inhibitors, has not been fully realized. Mutations alone, particularly those
identified in gene panels, are insufficiently informative to guide treatment selection. Tumors, especially
metastases, grow in complex ecosystems and exhibit striking heterogeneity and plasticity that allow them to
evolve dynamically under a series of pressures.
To overcome this limitation, we have now established a Functional Precision Oncology (FPO) platform,
whereby patient derived xenografts (PDX) and organoids (PDO) are established from tumors obtained from
patients with breast cancer. These models retain faithfully the complex molecular and biologic characteristics
of the originating tumors and, to that end, can predict clinical responses more reliably. Organoids are
amenable to medium-throughput drug screening and drug “hits” have been validated in PDXs, which currently
constitute the gold standard for preclinical drug evaluation. We integrate drug profiling results with genomic
studies to gain insights into determinants of treatment response or resistance and create genotype – drug
response correlations. We leverage this platform in the context of an ongoing clinical trial in early-stage breast
cancer, not only to generate patient-derived models, but also identify patients at high risk of metastatic
recurrence.
In the trial proposed herein (FORESEE: Functional precision oncology for metastatic breast cancer: a
feasibility trial, NCT04450706), we aim to systematically analyze the performance of this platform and gain
insights on the clinical activity of the proposed treatments in metastatic breast cancer. We establish PDOs
directly from biopsies of metastatic sites and perform PDO-based drug screens in women with metastatic
breast cancer, either newly diagnosed triple negative or hormone receptor-positive and Her2-negative who
have exhausted endocrine mono- and combinatorial therapies. With Aim 1, we will assess how often our PDO-
focused FPO pipeline leads to a treatment recommendation within 12 weeks. With Aim 2, we will assess how
often our FPO pipeline and concurrent commercial (gold standard) testing lead to treatment recommendations
and how often these recommendations overlap. The clinical efficacy of treatment selection informed by our
FPO assays will be captured (Aim 3). Collectively, these studies will investigate whether our PDO-based FPO
pipeline can be meaningfully incorporated in an investigational clinical practice and provide preliminary insights
of impact that can inform the design of a larger study.

Public health relevance
Project Narrative. Improving treatment selection using models that more faithfully recapitulate the biologic complexity of metastatic breast cancer holds promise in prolonging the intervals of tumor remission and overall survival, and mitigating the burden of metastatic breast cancer. Moreover, the impact could be immediate on the basis of personalized selection from a panel of available and readily accessible therapies. Patient derived organoids will advance our understanding about determinants of drug response and mechanisms of resistance and help us generate a comprehensive resource of genotype – drug response correlations.